Evolution and underlying genetics of thermal physiology and behavior in Drosophila

Project Summary
Background: Climate change is driving changes in the thermal environment around the world, with especially
strong impacts being felt on tropical islands. The range of temperatures that species can endure (thermal
tolerance) will be a determining factor for persistence in the face of climate change. Animals can also mitigate
the effects of changing environmental conditions by behaviorally preferring suitable refugia (thermal
preference). The genetic determinants of thermal tolerance and how they relate to the genetics of thermal
preference remain largely unknown. With this work, I will work to bridge this gap and enhance understanding of
the basic biology of thermal physiology and behavior.
Significance: The research that I propose will draw upon our lab’s historical datasets of the island’s natural
history and its fly community, coupled with a novel combination of classic physiology and behavior experiments
with cutting-edge genomic approaches in the lab to study how animals respond to a changing world.
Specific aims: In the first aim, I will measure the thermal niches of the São Tomé drosophilids (Drosophila
yakuba, D. santomea, and the continental outgroup D. teissieri) and dissect the genetic basis of thermal
tolerance in sister species of Drosophila. In Aim 2, I will seek the genetic basis of thermal preference among
the São Tomé drosophilids. In Aim 3, I will be positioned to answer the question whether thermal tolerance and
behavior are controlled by similar regions of the genome, and thus evolutionarily linked, by comparing the
genetic basis of thermal traits uncovered in the first two aims.
Methods: I will rear flies in environmental chambers across conditions ranging from 13 to 30°C, which spans
the range of temperatures that flies are exposed to on the island and measure survival and reproductive output as
proxies for thermal tolerance. I will use custom-designed chambers that expose the flies to a thermal gradient.
Flies will be free to move to regions within the gradient that they prefer, and I will track their movement using
video tracking techniques. I will use a genome-wide association studies (GWAS) to identify regions of the genome
that are associated with thermal tolerance and preference. Finally, I will quantify the amount of polygenic overlap
among the physiological and behavioral traits to test whether thermal physiology and behavior are under
similar genetic control.
Expected outcomes: The work that I am proposing here will provide a novel and comprehensive
understanding of the adaptive mechanisms that allow the São Tomé drosophilids to adapt to changing
environmental conditions, and it will provide valuable baseline analyses for ongoing long-term studies of
drosophilid evolution.

Public health relevance
Project Narrative Climate change is the most significant event of our time, and will result in environmental pressures that will drive rapid organismal adaptation to novel environmental conditions, or in the absence of the capacity to adapt, extinction. I will study the Drosophila species on the tropical island of São Tomé to understand the relationship between underlying genetics and thermal tolerance and thermal preference. My work will illuminate the evolutionary mechanisms that permit organismal adaptations to a changing world.